Methamphetamine and Other Substance Use Disorder Genetics in Thailand

Project Summary
Methamphetamine use disorder (MUD) is a hugely destructive public health problem that is surging worldwide,
including in many parts of the US and Asia. Thailand is an optimal site for studying the genetics of MUD, owing
to lower genetic and environmental heterogeneity than in the US, and lower research costs, in the greater
context of a devastating and widespread Thai epidemic of MUD, The Principal Investigators have formed the
international relationships and established the logistical infrastructures necessary for human genetic studies of
drug use disorders, including MUD, in Thailand, as shown during the prior iteration of this project; we collected
>4000 MUD-informative subjects (cases and exposed controls), twice the promised sample. Leveraging our
established and effective collaborations (Thanyarak Institute and Chulalongkorn University in Bangkok; Suan
Prung Hospital in Chiang Mai), our successful prior work supports the feasibility of this project. We will collect
and characterize a biobank sample for studies of substance use disorders (SUDs), especially MUD, as well as
other psychiatric disorders and behaviors. 6000 subjects will be recruited in Bangkok (primarily at SUD
treatment facilities) and 4000 in Chiang Mai (at Suan Prung, the major psychiatric hospital in the north of
Thailand and in the community); 10,000 in total, balanced with equal numbers of cases and non-MUD matched
controls. Subjects will be evaluated via the Thai MIND biobank instrument (the Thai version of an instrument
developed for a Million Veteran Program (MVP) project from previously-validated assessment modules). All
subjects' DNA will then be subjected to 3x low-pass whole-genome sequencing (WGS) at the Yale Center for
Genome Analysis, variants called, and the dataset subjected to genomewide association analyses. WGS will
allow the identification of common, rare, and copy number variants. We will undertake meta-analysis with other
East Asian (e.g. Taiwan – 2200 cases, 4400 controls) populations to increase power, and conduct trans-
ancestry meta-analyses with diverse ancestry groups (from the MVP sample and other large-scale biobanks
and cohorts). Following the identification of risk variants, we will use multiple approaches to investigate and
model MUD and other SUD polygenicity, and pleiotropy more broadly. We will also investigate the relationship
between genetic risk for MUD and other psychiatric traits, and implement causal inference analysis to
disentangle the pleiotropy of MUD with other psychiatric traits and disorders. Combining our newly-recruited
Thai cohort with our earlier Thai sample and other samples of diverse ancestral backgrounds will permit us to
fine-map MUD-associated loci and identify causal alleles across ancestry-specific LD patterns. Data will be
made available to the Psychiatric Genomics Consortium and results shared broadly. Results from this study
have the potential to advance greatly our understanding of genetic risk factors for MUD, especially in East
Asian populations underrepresented in genetic studies, leading to an improved understanding of the
neurobiology of MUD and, ultimately, improved approaches to its diagnosis, treatment, and prevention.

Public health relevance
Project Narrative Methamphetamine use disorder – MUD – is a serious problem in the US and worldwide; treatment options and understanding of its underlying biology are severely limited. Large-scale genomewide studies are a proven method to increase knowledge of a disorder's biology, and accordingly, we propose collection of 10,000 subjects in Thailand ascertained for MUD and other substance use and psychiatric traits, to conduct a whole- genome sequencing analysis; these will be meta-analyzed with other MUD samples. Results from this study have the potential to advance greatly our understanding of genetic risk factors for MUD, and therefore of MUD biology, especially in understudied East Asian populations.